Defining microtubule cytoskeleton regulatory pathways in development and disease

Title: Defining microtubule cytoskeleton regulatory pathways in development and disease
P.I. Kassandra Ori-McKenney
Project Summary:
Cellular architecture is governed by the organization of cytoskeletal networks and determines the functional
output of a cell. It is therefore essential to understand the regulatory mechanisms of cytoskeleton organization
as a cell develops, changes, or maintains its internal structure, because altering these processes can disrupt
cell function and ultimately lead to pathological conditions. The DYRK1a kinase signaling pathway is implicated
in intellectual disability disorders, neurodegenerative disease, and cancer. DYRK1a has important roles in a
range of cellular processes; however, the downstream molecular mechanisms of this kinase are largely
unknown. Our published and preliminary data have shown that DYRK1a regulates the microtubule
cytoskeleton directly by phosphorylating β-tubulin, and indirectly through phosphorylation of multiple
microtubule-associated proteins (MAPs). We have found that these MAPs exhibit diverse binding behaviors on
the microtubule lattice and differentially affect microtubule motors, highlighting an essential role for MAPs in
gating access to the lattice. The goal of this project is to dissect the multiple layers of regulation of microtubule-
based processes by studying the biochemical and genetic relationships between three kinases, eight MAPs,
and five motors both in vivo and in vitro. We aspire to construct a comprehensive network to elucidate the
multiple ways in which disease-relevant kinases modulate the microtubule cytoskeleton during different cellular
processes, from neuronal polarization to the establishment of specific dendritic morphologies to the
maintenance of neuronal architecture. To accomplish these goals, we will use an interdisciplinary approach
combining in vivo and ex vivo imaging techniques with in vitro biochemical assays. We will utilize the dendritic
arborization neurons of the Drosophila peripheral nervous system to study neuronal morphogenesis, dendritic
pruning, and polarized transport, combined with mammalian neuronal cell culture and expansion microscopy to
analyze MAP localization patterns under various conditions and determine how MAPs differentially direct
molecular motors to ensure proper targeting of cargoes to specific compartments. To complement these in vivo
experiments, we plan to perform in vitro reconstitution experiments using TIRF microscopy with purified MAPs,
microtubule motors, and kinases in order to elucidate their individual and collective effects on MAP binding,
microtubule dynamics and microtubule-based transport. We endeavor to comprehensively dissect kinase-MAP
networks at the protein level and at the cellular level in order to understand how these pathways contribute to a
diversity of human pathologies.

Public health relevance
Title: Defining microtubule cytoskeleton regulatory pathways in development and disease P.I. Kassandra Ori-McKenney Project Narrative: Minibrain/DYRK1a kinase has been implicated in a range of intellectual disability disorders and neurodegenerative diseases. Little is known about the molecular network of this kinase and the distinct roles it plays during different cellular functions, but we have found that DYRK1a regulates the microtubule cytoskeleton on several levels. This proposal seeks to delineate the pathways that orchestrate the dynamic microtubule cytoskeleton by combining live imaging of cellular and organismal systems with in vitro biochemical reconstitution assays. The overall goal of this project is to elucidate the multifaceted mechanisms of the DYRK1a network in regulating essential microtubule-based processes in order to provide insight into the contribution of this pathway to multiple human diseases.